Investigating the small peptide Tsr37, its role in virulence, and activation of the SaeRS two component system in Staphylococcus aureus

PROJECT SUMMARY/ABSTRACT
Staphylococcus aureus is both a commensal of humans and a highly dangerous bacterial pathogen. S. aureus
pathogenesis is mediated by a large repertoire of secreted and cell wall-associated virulence factors. To mount
successful infections the bacteria must regulate expression of the genes encoding these virulence factors in a
temporal and spatial manner. Two component signal transduction systems (TCS) are one type of regulatory
circuit that bacterial cells use to sense their environment and modify gene expression accordingly. The Sae
TCS is a global regulator of secreted protein production in S. aureus and a variety of well-studied virulence
factors are known to be directly controlled by the Sae system. Activity of the Sae system is dependent on the
balance between the kinase and phosphatase activities of the sensor protein SaeS. Human neutrophil peptide
1 (HNP-1) is known to activate SaeS kinase activity, while the Sae auxiliary proteins SaePQ induce
phosphatase activity. Recent work in our laboratory has identified a potent, novel activator of the Sae system.
Overexpression of the tsr37 gene in S. aureus results in a dramatic increase in Sae activity and upregulation of
Sae target genes. In this proposal we will investigate the nature of the tsr37 gene product, investigate how
tsr37 activates the Sae system, and determine the contribution of tsr37 to virulence. In addition, we will study
the in vivo expression profile of tsr37 to determine when and where it is expressed during systemic infection.
We anticipate that the results from this study will demonstrate that a short protein, Tsr37, acts as a potent
activator of the Sae TCS. Understanding how a small peptide interacts with, and activates, the Sae system
could inform future studies to design Sae inhibitors which could be used as a novel therapeutic to treat S.
aureus infection.

Public health relevance
PROJECT NARRATIVE The Sae regulatory system controls expression of a large number of virulence genes in Staphylococcus aureus. We have identified a novel protein, Tsr37, that is a potent activator of the Sae system. In this proposal we will further characterize Tsr37, investigate how it activates the Sae system, and determine its role during infection.